The next iteration of the AMP-T2D Knowledge Portal

Project Summary
In this supplement, we propose to make the LD-score regression (LDSC) software package – a widely used
tool by the human genetics community that has been cited thousands of times – more compliant with the goals
of open science. In our original project, UM1DK105554 (“The next iteration of the AMP-T2D Knowledge
Portal”), we proposed to continue development of the Common Metabolic Disorders Knowledge Portal
(CMDKP) by enhancing its infrastructure to aggregate, analyze, and visualize genetic and genomic datasets
and results. As part of this work, we have added LDSC to the CMDKP. LDSC calculates statistics between
pairs of GWAS datasets or between a GWAS dataset and a genomic annotation, which we use to help users
query and interpret data in the CMDKP. In the process of adding LDSC to the CMDKP, we made several
modifications to its codebase to reduce computational overhead. These in turn identified three additional
improvements that could be made to the LDSC software package to make it more compliant with the goals of
open science. First, by implementing batch dataset processing natively within the LDSC codebase, we would
make it possible to easily scale LDSC on the cloud and enable users to apply it to their own GWAS data
across many traits or annotations. Second, by implementing a software service and API to which users could
upload their own GWAS data, and then obtain cross-trait correlations or annotation enrichments across all
datasets in the CMDKP, we would provide a new dissemination channel for LDSC targeted at users who do
not want to download any data or code. Third, by refactoring LDSC into more a modular set of libraries within a
modern language, we would make it easier to maintain, extend, and reuse. Collectively, these improvements
will advance open science by making a widely used software tool (a) parallelizable, cloud-ready, refactored,
and more extensible; and (b) more reusable through an easy-to-use new software service and API. They will
advance the goals of our original project by providing a new mechanism to interact with data in the CMDKP
and contribute new datasets to it.

Public health relevance
Project Narrative This project will make the LD-score regression software package – a widely used tool by the human genetics community that has been cited thousands of times – more compliant with the goals of open science. We will enable it to batch process many datasets at once, make it available as a public web-service to enable its use without downloading any code or data, and refactor its codebase to be easier to reuse and extend. The project will make this important tool more widely available, and it will provide a new way for users to interface with the Common Metabolic Diseases Knowledge Portal, the subject of our parent project.